Stem cell-derived exosomes to ameliorate chemobrain

ABSTRACT
Numerous clinical and preclinical studies have established the debilitating neurocognitive side
effects of various chemotherapy regimens for the treatment of cancer, often referred as
chemobrain. With substantial increases in the number of cancer survivors, over 16.9 million in the
U.S. alone, cognitive function following cancer treatment is considered as one of the most critical
criterion for evaluating therapeutic outcome and for determining long-term quality of life. The
situation is confounded further by the conspicuous absence of satisfactory treatments for reducing
the progressive neurocognitive sequelae associated with non-CNS cancer therapies. This
application is in response to a specific RFA (PAR-21-329) to investigate interventions designed
to prevent or reduce the adverse neurocognitive sequelae following cancer therapy. Our pre-
clinical studies have shown long-term consequences of chronic chemotherapy
(cyclophosphamide, CYP; Adriamycin, ADR monotherapy) including cognitive impairments, loss
of neuronal architecture, spine integrity and neuroinflammation. We posit that neuroinflammation
is one of the major contributory factors for long-term CNS dysfunction and that human neural
stem cell (hNSC)-derived extracellular vesicle (EVs) treatment can ameliorate adverse
neurocognitive and inflammatory sequelae associated with chemobrain. Our recent data show
that hNSCs or hNSC-derived EV reverse cancer therapy (CYP or irradiation, IRR)-induced
cognitive impairments, neuron and spine damage and, neuroinflammation. Intra-venous (retro-
orbital vein, RO) injections of hNSC-EVs showed long-term neuroprotection in the IRR brain. We
have also identified candidate miRNA within the EV cargo, with gene targets relevant to the
molecular, structural and behavioral improvements observed in the cancer therapy-exposed
animals following EV injection. Importantly, in vivo expression of miR-124-3p reversed IRR-
induced cognitive deficits and neuroinflammation. Based on the foregoing, we propose a
comprehensive series of studies designed to test the effectiveness hNSC-EV and determine an
EV-derived candidate miRNA-based mechanism to ameliorate chemobrain and
neuroinflammation in routinely used adjuvant chemotherapy regimens (Carboplatin-Taxol, ADR-
CYP) to control the growth of ovarian and breast cancer. Our research design will delineate long-
term neuroprotective effects of RO injections of hSNC-EV or in vivo expression of miR-124-3p
following adjuvant chemotherapy regimens in disease-free or xenograft cancer mouse models.
These studies will also elucidate the safety, toxicity and pharmacokinetics of hNSC-EVs therapy
in the context of cancer. Thus, this project is based on a foundation of strong published and
preliminary data supporting our rationale.

Public health relevance
PROJECT NARRATIVE Cancer therapy-induced cognitive dysfunction (CRCI) or chemobrain is one of the major quality of life issue for cancer survivors. With over 16.9 million cancer survivors alive today, assessing long-term neurocognitive complications and effective clinical recourse is now considered the most important clinical criterion for evaluating therapeutic outcome. This proposal (in response to a chemobrain RFA, PAR-21-329) will delineate effectiveness of systemic injections of human neural stem cell-derived extracellular vesicles and miRNA-based mechanism of neurocognitive benefits using intact and cancer mouse models to ameliorate CRCI.